Interactive Processes in Photoreceptor Axon Targeting

Neural circuit development requires neuronal processes to find the correct synaptic partners within a
complex environment. Dynamic interactions between processes from different cell types often result in a
reproducible layered organization that simplifies this connectivity problem. For example, in the Drosophila
visual system the ultraviolet-sensitive R7 photoreceptor axons always connect to their post-synaptic Dm8
partners in the M6 layer of the medulla. Previous studies have identified factors required in R7 for its normal
projection pattern, yet little is known about the cellular and molecular cues in the environment that it
recognizes. The goal of this proposal is to close this gap by identifying the neurons and signals that shape
the environment of the medulla and guide R7 through it. The first aim is based on the discovery that the
CUB-LDL protein Lost and found (Loaf) is required in R7 only when it is also present in other cells in the
environment. Determining the consequences of varying the levels of Loaf in different sets of neurons will
distinguish between two hypotheses: that matching levels of Loaf in R7 and Dm8 promote synapse
formation between them, or that R7 competes with other Loaf-expressing neurons for access to its target
layer. Other experiments will investigate whether Loaf mediates homophilic or heterophilic adhesion or
traffics other molecules to the synapse. The second aim will examine how Plexin A (PlexA) expressed on
tangentially projecting neurons contributes to the separation of medulla layers. The proposed experiments
will determine whether PlexA acts as a receptor to autonomously guide tangential neurons, which then
provide guidance information to other processes, or as a ligand that is itself recognized by the ingrowing
processes of medulla neurons and/or R7. The third aim will make use of a recent transcriptomic analysis to
determine which of the cell-surface or secreted molecules that are enriched in Dm8 are necessary to
promote synapse formation with R7. The most interesting candidate will be selected for further analysis of
its mechanism of action. The cellular and molecular interactions defined in this study are likely to reveal
principles that will be applicable to the assembly of more complex neural circuits, and to provide insight into
the nature of the defects in neurodevelopmental disorders such as autism and epilepsy.

Public health relevance
Developing neurons must form the right connections in order to generate functional neural circuits. The color-sensitive photoreceptors in the fruit fly Drosophila are a good model system to investigate how neuronal processes find and recognize the correct partners. The molecules and mechanisms involved in interactions between the developing eye and brain will provide insight into how human circuits develop and into the underlying defects in neurodevelopmental disorders.